Cellular Molecular Mechanisms of Alanyl-Glutamine Oral Rehydration and Nutrition

PROJECT SUMMARY Laboratory and clinical studies in Northeast Brazil demonstrate the benefits of a novel alanyl- glutamine-based oral rehydration and nutrition therapy (Ala-Gln ORNT) in speeding the repair of damaged intestinal barrier function in cell culture, animal models, patients with AIDS, and in children from an urban shantytown with a high incidence of enteric infections and undernutrition. The mechanisms by which Ala-Gln enhances intestinal barrier repair remain unclear; however, recent data from our laboratory suggest a role of the epidermal growth factor receptor (EGFR), a key regulator of intestinal homeostasis and repair mechanisms. Gaps in knowledge regarding: 1) the minimal effective dose of oral Ala-Gln to improve gut integrity in undernourished children and 2) the extent to which Ala-Gln ameliorates intestinal inflammation, further limit our understanding of Ala-Gln ORNT as a promising intervention for the vicious cycle of diarrhea and undernutrition in resource-limited settings. In this proposal, we will seek to further define the mechanisms of intestinal repair by Ala-Gln using state-of-the art molecular and genetic approaches in a weanling mouse model of malnutrition and a dose-response study in undernourished Brazilian children. Our Specific Aims are to: 1) Define the role of EGFR in mediating the Ala-Gln ORNT reversal of malnutrition-induced enteropathy in a weanling mouse model of malnutrition, and 2) determine the mechanisms and dose-effects of Ala-Gln for restoration of intestinal barrier function in undernourished Brazilian children. We hypothesize that: 1) EGFR is required for homeostatic responses to Ala-Gn in undernourished weanling mice, 2) oral Ala-Gln will improve intestinal permeability in undernourished children at lower doses than previously tested, and 3) oral Ala-Gln reduces intestinal inflammation in undernourished children. The proposed studies will have important implications not only for diarrhea and malnutrition, but for several other infectious and digestive disorders. Furthermore, this outstanding training opportunity will provide me with the foundation necessary for a successful career as an independent global health scientist.

Public health relevance
PROJECT NARRATIVE Diarrheal diseases and diarrhea-associated undernutrition remain predominant causes of morbidity and mortality worldwide. Our proposal addresses the mechanisms of a novel Alanyl-Glutamine oral rehydration and nutrition therapy (Ala-Gln ORNT) as a promising intervention for the acute and long-term nutritional effects of diarrhea and thus contribute to ameliorating this morbidity and mortality. __SpecificAimsTextDelimiter__ CELLULAR AND MOLECULAR MECHANISMS OF ALANYL-GLUTAMINE ORAL REHYDRATION AND NUTRITION THERAPY SPECIFIC AIMS AND HYPOTHESES Several host factors underlie the pathogenesis of the reciprocal cycle of childhood diarrhea and undernutrition in developing countries. These include intestinal inflammation, mucosal damage, and alterations in intestinal barrier function that lead to malabsorption, growth failure, and heightened susceptibility to recurrent and prolonged episodes of diarrhea. Recent studies from Northeast Brazil demonstrate the benefits of a novel alanyl-glutamine-based oral rehydration and nutrition therapy (Ala-Gln ORNT) in speeding the recovery of damaged intestinal barrier function in cell culture, animal models, patients with AIDS, and underweight children. In tissue culture, we have found that Ala-Gln increases epithelial survival and proliferation and activates epidermal growth factor receptor (EGFR), a key regulator of intestinal homeostasis. In a Northeast Brazil mouse model of weanling malnutrition, we have determined that Ala-Gln improves weight gain and gut integrity, as well as epithelial survival and proliferation. The specific mechanisms by which Ala-Gln enhances intestinal repair remain unclear. Likewise, the optimal dosing of Ala-Gln in undernourished children and the extent to which Ala-Gln mitigates intestinal inflammation have yet to be determined. Hence, in this proposal we will seek to further define the mechanisms of Ala-Gln-mediated intestinal repair using state-of-the art molecular and genetic approaches in a weanling mouse model of malnutrition and a dose-response study in undernourished children from Northeast Brazil. Our Specific Aims are to: 1. Define the role of EGFR in mediating the Ala-Gln ORNT reversal of malnutrition-induced enteropathy in a weanling mouse model of malnutrition. Hypothesis: EGFR is required for intestinal homeostatic responses to Ala-Gln in mice with malnutrition enteropathy. 2. Determine the mechanisms and dose-effects of Ala-Gln for restoration of intestinal barrier function in malnourished children. Hypothesis: Ala-Gln supplementation will improve gut integrity (as measured by urinary lactulose:mannitol excretion) at lower doses than previously studied and reduce intestinal inflammation (as measured by fecal cytokines and lactoferrin) in wasted or underweight children. The proposed complementary studies will significantly enhance our understanding of the roles of EGFR, inflammation, and dose-effects in alanyl-glutamine-mediated intestinal homeostasis, with important implications not only for the vicious cycle of diarrhea and malnutrition, but for several other infectious and gastrointestinal disorders. In addition to addressing mechanistic questions, these studies will provide the applicant with a rich environment for intense laboratory and clinical research training at Cincinnati Children's Hospital and the Federal University of Ceará in Brazil. Both sites have long-standing records of funded research and robust support of young investigators and will thus provide an outstanding environment for the PI's ongoing transition to a successful career as an independent global health scientist.